Administrative Core

Abstract
The broad objectives of the Administrative Core (Core A) of the Gonorrhea Vaccine (GV)-CRC are
to provide the infrastructure needed to help the Center meet its long-term goal of increased
understanding and improved control measures for chlamydia and gonorrhea infections. Dr. Ann
Jerse will be the Core Leader and a Core Manager will assist her in the running of the core. The
activities of Core A are organized around the following five specific aims and a management plan
has been developed to address each aim. Aim 1 is to foster interactive and synergistic interactions
between Center PIs, co-PIs and Core Leaders to maximize research accomplishments and
increase the types of significant breakthroughs that occur when experts in different fields work
together. Mechanisms to accomplish this goal include monthly teleconferences for Center
investigators and annual GV-CRC meetings where Center PIs, coPIs and Core Leaders present
their progress. An outside scientific advisory board (SAB) composed of researchers with diverse
experience in STIs will attend one of the GV-CRC meetings and provide critiques on the progress
of individual Research Projects, the Research Cores, and the overall Center. Aim 2 is to provide
funds, mentorship, and networking opportunities to talented new investigators working in STI
research through the Developmental Research Project (DRP) program. Core A will solicit calls for
applications and organize the review panel and review process by which awardee will be selected.
Core A will also play a role in developing a training plan for the awardee and will provide the DRP
awardee with the opportunty to attend and present at an annual NIAID programmatic STI CRC
meeting. Aim 3 is to actively facilitate good communications between the Henry Jackson
Foundation, who will administer the awards and subawards of the Center, and administrative
personnel at the different institutions within the Center. In this way, the accounting responsibilities
of the center can be better discharged in an efficient and straightforward manner. Core A will
provide administrative oversight with respect to maintaining all assurances for animal and human
use. Aim 4 is to regularly communicate with NIH/NIAID program staff so that our progress is
transparent and we are aware of changes in programmatic focus. To promote these interactions,
NIAID program staff will be invited to the annual internal GV-CRC meetings. Aim 5 is to broaden
networks within the STI research community by actively seeking and identifying potential
collaborations between Center researchers and investigators at other Centers. Besides helping to
identify such collaborations, Core A will consult with NIAID program staff for information on
expertises or technologies held by other Centers that might help PIs within our center.